Early Cognitive Impairment as a function of Alzheimer's Disease and Trauma

Risk for dementia, including late-onset Alzheimer’s disease (AD) and vascular dementia, is
determined by a complex mix of environmental, health, and genetic factors. Veterans have
higher rates of vascular problems, PTSD, combat trauma, and traumatic brain injuries, which
have all been linked to increased rates of age-related cognitive impairment and dementia.
Further, studies have indicated that these Veteran-relevant exposures may interact with AD
genetics to further increase the risk of cognitive decline. This application represents an
outgrowth of a project examining dementia and combat related gene by environment (GxE)
interactions in the Million Veteran Program (MVP), one of the world’s largest electronic-medical
record (EMR) linked biobanks. The original 2-year MVP Gamma project (MVP015) generated
working definitions of mild cognitive impairment (MCI), AD, and all-cause dementia from the VA
EMR. These were examined for association with combat exposure, head injury, and PTSD in
aging Veterans. We found evidence that head injury, combat, PTSD symptomatology, and AD
genetic risk variants were all associated with self-reported cognitive difficulties and MCI in
Veterans as young as 45-55, and with AD and related dementias in those age 65+. We
additionally identified GxE interactions between candidate variants in several genes and
combat/head injury on MCI and AD risk. In this application, we propose expanding on the initial
study, by 1) performing a genome wide association study (GWAS) of Dementia cases and
controls in multiple ancestry groups as well as examining the performance of GWAS-based
genetic risk scores in African American and Hispanic MVP participants, 2) performing
multivariate GxE analyses examining a range of Veteran relevant health exposures, 3) Further
developing and validating dementia diagnoses in MVP for genetic analyses including a machine
learning based method of identification of Dementia cases. This project will expand on our
continuing work and increase our knowledge of the impact of Veteran specific environmental
exposures and their interactions with AD genes on risk for AD and dementia.

Public health relevance
Dementia is a serious issue for Veterans, particularly given the increasing age of Veterans in VA. We will use data from the Million Veteran Program (MVP), one of the world’s largest biobanks, to examine the genetic underpinnings of dementia risk in Veterans. This includes genome-wide association studies of MVP participants of multiple ancestry groups. We will also use new methods to increase the accuracy of dementia genetic risk scores in African American and Hispanic populations, reducing a possible source of health disparities. In addition, we will look for genetic variants that interact with combat related exposures and health problems that occur often in Veterans to increase risk of dementia. Finally, we will refine our algorithms for identifying cases of dementia in the VA electronic medical record, which will increase our power to detect genetic associations. All of this will represent a leap forward in what is known about the genetic architecture of dementia, and in African American and Hispanic Veterans in particular.